Quantifying patient-specific changes in neuromuscular control in cerebral palsy

Project Summary
Walking enables independence and exploration in daily life. For people with cerebral palsy (CP), a brain injury
near the time of birth alters their ability to move and participate in daily activities. Treatments seek to improve
walking function, but the processes by which people with CP adapt and learn new movement patterns are
poorly understood. Our prior research demonstrated that patient-specific measures of motor control (i.e., how
an individual recruits and coordinates their muscles) are important indicators of walking function and
treatment outcomes. Children with more impaired motor control compared to nondisabled peers have worse
function and worse outcomes after treatments like orthopedic surgery or selective dorsal rhizotomy. The
premise of our proposed research is that patient-specific measures of adaptation are equally important to
understand and inform care, but we lack methods to quantify adaptation or effectively induce motor learning.
Whether adaptation is altered in CP and whether targeted training can amplify adaptation to improve walking
function remains unknown. Multimodal feedback training is a promising approach to support adaptation and
motor learning, but few studies have evaluated adaptation with real-time feedback training during walking or
its impacts on walking function. The proposed research seeks to fill these gaps by completing the systematic
experimental analyses necessary to quantify walking adaption rates (Aim-1) and determine whether repeated
exposure to multimodal feedback training can alter adaptation rates (Aim-2) to induce motor learning and
improve walking function (Aim-3). Specifically, we examine adaptation rates in response to multimodal
feedback training that targets plantarflexor function, a key muscle group for walking that is nearly universally
impaired in CP. We provide multimodal feedback using (1) sensorimotor feedback from adaptive ankle
resistance delivered via a light-weight, wearable robot and (2) audiovisual feedback of plantar flexor activity
from EMG recordings. By evaluating responses of children with CP to this feedback training – both individually
and combined – this research will establish the scientific basis to quantify and understand adaptation and
motor learning in CP.

Public health relevance
Narrative The processes by which people with cerebral palsy adapt and learn to coordinate their muscles in order to move and explore the world remain unclear. To improve movement and function, new methods are needed to probe these processes and develop targeted treatments. The purpose of this research is to use feedback training to quantify walking adaptation and improve walking function for people with cerebral palsy.